Novel peptides for resuscitation

Cardiac arrest (CA) is a leading cause of death around the globe. In the USA, it affects about 650,000 people
annually with an overall survival rate for out-of-hospital cardiac arrest less than 10%. Despite this enormous
public health burden, no pharmacological drugs exist to improve CA survival. This proposal is a renewal
application of R01HL147031-01 that investigated a novel cell-permeable biological peptide TAT-PHLPP9c to
improve CA outcome. This peptide inhibits the phosphatase PHLPP and activates Akt in the heart and brain
within minutes after intravenous administration during cardiopulmonary resuscitation (CPR). Remarkable
improvement in neurologically intact survival in both mouse and swine CA models was demonstrated, with new
biomarkers of metabolic resuscitation identified. However, in addition to metabolic dysfunction, marked
intravascular coagulation in the microcirculation of organs after CA also contributes to poor outcomes. This
renewal application builds upon new preliminary data showing that in addition to Akt-related metabolic recovery,
platelet activation and related thrombo-inflammation via the G Protein α13-Integrin β3 interaction affects CA
outcome. Proposed work will examine a novel treatment strategy for CA that combines the use of TAT-PHLPP9c
and M3mP6, a lipid-stabilized, high-loading peptide nanoparticle designed to inhibit integrin signaling and platelet
activation. Our pilot studies suggest substantial platelet activation and related inflammation within hours after
both mouse and swine CA, with only partial attenuation of this thrombo-inflammation by TAT-PHLPP9c.
Furthermore, M3mP6, when given during CPR, provides substantial synergistic benefit from TAT-PHLPP9c to
5-day CA survival in a mouse CA model. New aims will use these two complementary novel peptides to examine
the synergistic roles of metabolic derangement and thrombo-inflammation in CA survival, and develop a
transformative approach to CA with the potential to protect against even prolonged >10-15 min of untreated
cardiac arrest. New proposed work will:
Aim 1. Examine whether combined treatment of TAT-PHLPP9c and M3mP6 during CPR improves 5-day
neurologically intact survival after mouse CA.
Aim 2. Study the mechanisms of the synergistic effects of these two peptides in the heart and platelets.
Aim 3. Validate the efficacy of TAT-PHLPP9c and M3mP6 in a swine CA model.
The concept of administration of novel cell-permeable peptides during CPR to protect against two critical aspects
of post-CA syndrome is practical, innovative and highly translational. New mechanistic insights into metabolic
injury and thrombo-inflammation and how they interact to affect CA survival would have great potential to develop
novel approaches for CA care. Given the magnitude of protection the combined peptides demonstrate in
preliminary work, this proposal has potential to transform cardiac arrest care.

Public health relevance
Cardiac arrest (CA) is a leading cause of death around the globe. In the USA, it affects about 650,000 people annually with an overall survival rate for out-of-hospital CA less than 10%. Despite this enormous public health burden, no pharmacological drugs exist to improve CA survival. This proposal is a renewal application of R01HL147031-01 that investigated a novel cell-permeable biological peptide TAT-PHLPP9c to improve CA outcome. In this proposal, we aim to investigate a novel treatment strategy by combining TAT-PHLPP9c and M3mP6 that inhibits thrombo-inflammation to synergistically improve neurologically intact survival after CA.